Mechanisms underlying adhesion and colonization in pneumococcal keratitis

Project Summary/Abstract
Streptococcus pneumoniae is one of the top bacterial causes of keratitis worldwide and can lead to significant
vision loss. The mainstay of therapy continues to be antibiotics; however, bacteria are not always susceptible,
and antibiotics are unable to reduce the host- and bacterium-mediated damage associated with S. pneumoniae
keratitis. Our findings strongly indicate that the outer polysaccharide capsule of S. pneumoniae, considered a
major virulence factor of this organism, impedes attachment of the bacteria to the corneal surface. Preliminary
data show that the bacteria produce markedly less capsule when adhered to corneal epithelial cells, which
suggest that they regulate capsule to adapt to the corneal niche. Therefore, our central hypothesis is that S.
pneumoniae adapts to down-regulate capsule in the present of corneal cells so that attachment and
persistence are increased. We will test our hypothesis by comparing capsule quantities of bacteria that are
adherent to corneal cells and the corneal surface to bacteria that are not adherent. We will then determine the
genes that are necessary for corneal attachment and colonization by a prioritized genetic screen of a library of
mutants in vitro and in vivo, followed by validation with functional analyses with targeted mutations. The long-
term goals of this study are to identify and characterize the factors that repress bacterial capsule in the cornea
and promote attachment to cause keratitis. Understanding the processes of regulation and colonization will aid
in driving development of novel therapies to preserve the cornea.

Public health relevance
Project Narrative Streptococcus pneumoniae is a major cause of bacterial keratitis and is a threat to vision. This bacterium controls its gene products to adapt to the eye, and this research aims to identify and characterize how this control works. Knowledge of how this organism can attach to and infect the eye will guide future therapy.